Epigenetics, accelerated aging, and cardiovascular health during breast cancer treatment

PROJECT SUMMARY
Although survival from breast cancer (BC) has improved, BC treatment is associated with an increased risk of
cardiovascular (CV) complications due in part to the cardiotoxic effects of BC treatment. BC treatments are also
linked to reduced exercise capacity and cardiac function, which may contribute to the increased risk of CV events
in women receiving BC treatment. Accelerated aging is one possible mechanism that could explain the declines
in exercise capacity and cardiac function observed in women treated for BC. BC treatment is known to cause
age-related cellular changes through multiple mechanisms including epigenetic alterations, such as DNA CpG
site methylation which is a well-known marker of accelerated aging. Accelerated aging has been linked to CV
disease risk and declines in cardiac function in the general population. However, no study to date has examined
the association between accelerated aging and exercise capacity or cardiac function in BC patients. Identifying
the mechanisms by which reduced exercise capacity and cardiac function during BC treatment occur could lead
to targeted interventions. For instance, accelerometer-assessed physical activity in a healthy community-based
cohort was shown to negate the effects of accelerated aging. This suggests that the rate of epigenetic age
acceleration may be modified by physical activity, identifying a potential lifestyle modification to improve exercise
capacity and cardiac function in BC patients. The purpose of the proposed study is to examine epigenetic
changes during BC treatment and their association with changes in exercise capacity and cardiac function during
BC treatment. We will utilize samples from the NCI-funded Understanding and Predicting Fatigue, CV Decline
and Events after BC Treatment (UPBEAT) study, a prospective cohort of BC patients receiving cancer treatment.
We will quantify DNA CpG site methylation in 100 samples of women with BC and 20 samples of non-cancer
controls collected at both enrollment and 3-months after enrollment using the Illumina Infinium MethylationEPIC
v2.0 BeadChip. We will characterize epigenetic changes during BC treatment compared to non-cancer controls
and examine the association between epigenetic aging with changes in exercise capacity and cardiac function
in women receiving BC treatment. The UPBEAT study is an ideal dataset to investigate the proposed research
study as it obtained DNA specimens required to examine epigenetic changes prior to and during BC treatment,
includes non-cancer controls, and has detailed data on CV risk factors, treatment data, physical activity,
medications, and CV comorbidities and longitudinal data on exercise capacity and cardiac function. Findings
from this study will aid in identifying mechanistic pathways in which BC treatment impacts exercise capacity and
cardiac function. Understanding the role of accelerated aging in relation to exercise capacity and cardiac function
in BC will provide information needed to develop targeted interventions with the long-term goal of reducing the
risk of CV events in BC survivors. Additionally, this data could be used to identify BC patients at high risk of
developing CV dysfunction and reduced exercise capacity, which could be used to improve risk stratification.

Public health relevance
PROJECT NARRATIVE Although survival from breast cancer has improved, breast cancer treatment is associated with the risk of cardiovascular complications, due in part to treatment-related reductions in cardiac function and exercise capacity. This study will examine epigenetic changes, a marker of accelerated aging, during breast treatment and their associations with changes in exercise capacity and cardiac function during breast cancer treatment. Identifying the mechanisms by which reduced cardiac function and exercise capacity during breast cancer treatment occur could lead to the identification of factors that mitigate accelerated aging and the development of targeted interventions.